Molecular mechanisms that control polarity and asymmetric cell division

Project Abstract
Animal cells are asymmetric, often containing different proteins at distinct areas of the
membrane. For example, the cells that line our digestive tract are poised to take in nutrients
from one side of the cell and deliver them to the rest of the body at the other side. This proposal
examines the activity of the Par complex, a set of proteins responsible for creating and
maintaining different regions of animal cell membranes. We are also examining how cellular
asymmetries are translated into the complex organization seen in animal tissues and organs.
One mechanism for creating structure within tissues is to create different cell types, such as
neurons with the brain. In general, our work aims to understand how cells process information to
speciﬁcally target polarity and fate determinants to the appropriate region of the cell at the right
time, activate these complexes once they're localized, and how the activity of these complexes
is translated into complex cellular functions, such as differentiation.

Public health relevance
Narrative Many cells in our body, such as skin cells that provide a physical barrier to the environment, are polarized and loss of polarity is a hallmark of many diseases, including cancer. We are investigating how animal cells are polarized and how polarity is used in specialized processes such as differentiation. As the loss of polarity is associated with human disease, improving our understanding of the molecules that control this process will contribute to our knowledge of the mechanisms of disease states.